Mechanisms Driving Metabolic Shifts in the Intestinal Epithelium

Mechanisms Driving Metabolic Shifts in the Intestinal Epithelium
Project #R01DK126446
Project Abstract
Cells of intestinal epithelium do not exhibit a uniform metabolic state. Metabolic shifts accompany
transitions during adult stem-crypt-villus homeostasis. Metabolic shifts also occur in response to injury and in
colon cancer. The long term goal of this research is to define targetable metabolic regulatory processes to treat
diseases and disorders of the intestine. The immediate goal of this proposal is to define the regulatory
mechanisms that govern metabolic shifts during the epithelial cell lifespan.
OX-PHOS gene expression levels are high in intestinal stem cells, low in crypts, and highest in villus.
Dynamic expression of OX-PHOS genes parallels the metabolic transitions of the epithelium. However, the
mechanisms regulating cellular metabolism during epithelial cell transitions in the intestine are unclear. We
have generated new mouse models that identify transcription factors contributing to epithelial metabolism.
Aim 1 of the proposed studies will drill down to identify how the transcription factor, YY1, promotes
expression of genes that drive the electron transport chain. We will test the hypothesis that YY1 regulates
enhancer-promoter chromatin looping to promote expression of these key genes required for mitochondrial
respiration. We will also test the hypothesis that YY1 function differs in intestinal stem cells versus in their
progeny in crypts or in villus enterocytes. State-of-the-art epigenomic and proteomic assays will be employed
in the context of novel mouse models. We expect these regulatory mechanisms are important to drive
metabolic shifts that occur upon exposure to low oxygen environments during tissue damage/regeneration or in
oncogenesis. Therefore, we will also investigate these regulatory mechanisms in regenerative foci after tissue
damage to discern whether YY1 controls the metabolic shifts that accompany tissue regeneration.
Aim 2 will look at regulation of an important energy source for mitochondrial respiration – fatty acid
oxidation. We will test the hypothesis that HNF4 transcription factors promote fatty acid oxidation to support
intestinal stem cell renewal. A combination of metabolomics, epigenomics, and organoid-based assays will be
employed, using novel mouse models. We will further test the hypothesis that the Estrogen-Related Receptor
is an important and novel partner factor of HNF4, and that together, HNF4 and ESRRA shape the response of
the intestinal epithelium in response to a change in dietary fat.
To our knowledge, these studies would provide the first link between the core intestinal transcription factor
regulatory networks and the metabolic state required for intestinal stemness. Excess dietary fat increases risk
for obesity and colon cancer. Our studies will move the field forward in linking how diet and metabolites can
intersect with the transcriptional regulatory mechanisms of the intestinal epithelium. Together, these studies will
reveal how metabolic transitions are regulated in the intestine during normal homeostasis, as well as under
pathological situations (epithelial regeneration or under high-fat diet).

Public health relevance
Project Narrative: The cells lining our intestine are critical for absorbing nutrients, preventing infection, and are the source of colon cancer. These cells are not uniform, but perform specialized functions, and in turn, these different cells utilize energy differently. The proposed work is relevant to human health because it will reveal how cellular metabolism is controlled in different cell types lining the intestine; and new mechanisms of metabolic control could provide therapeutic entry points to bolster regenerating cells to repair the intestine or suppress changes induced by an obesogenic diet.